Mechanisms of BER in Genomic Integrity and Epigenetic Regulation

An overarching goal of our research is to understand how the base excision repair (BER) pathway maintains
genomic integrity and mediates epigenetic regulation, and how deficiencies in BER impact human health. A
major focus is to discover how DNA glycosylases, which initiate BER, find and excise damaged or modified
forms of 5-methylcytosine (mC). The most abundant modified DNA base in nature, mC is critical for epigenetic
regulation in plants and animals and for restriction modification in archaea and bacteria. However, cytosine
methylation also poses a danger because mC deaminates to T, generating G/T mispairs and C to T mutations
that threaten genomic and epigenetic integrity and causes human diseases including cancer. Countering this
threat are three different types of glycosylases that excise T from G/T mispairs; TDG and MBD4 in mammals
and MIG in archaea and bacteria. While most glycosylases excise bases that are foreign to DNA (e.g., uracil)
these enzymes face the daunting task of removing thymine bases arising by mC deamination but not those in
the vast background of A:T pairs or in polymerase-generated G/T mispairs. Because glycosylase action on
undamaged DNA is mutagenic, the specificity of these G/T glycosylases is critical, yet it is poorly defined. The
current paradigm holds that specificity involves recognition of the mismatched guanine. We will rigorously test
this model and investigate other potential specificity factors, to define the mechanism of G/T glycosylase
specificity. Our studies will reveal features of TDG and MBD4 that may account for inefficient repair of mC
deamination, a potential cause of point mutations implicated in cancer and genetic disease. BER also functions
in epigenetic regulation by serving to “erase” mC through active DNA demethylation. An established pathway
in vertebrates involves oxidation of mC by a TET enzyme to give three oxy-mC products (hmC, fC, caC),
excision of fC or caC by TDG, and subsequent BER to yield unmodified C. Our studies will address major gaps
in the understanding of this essential pathway, by defining how TDG recognizes and removes fC and caC and
how it is recruited to sites of DNA demethylation. We are also interested in how post-translational modifications
regulate BER, and our current focus is on determining how TDG is regulated by SUMO modification. TDG is
sumoylated at a single site, and it has a SUMO-interacting motif (SIM) that binds SUMO domains, including an
intramolecular SUMO. While TDG is considered a model for understanding how sumoylation can regulate
enzyme activity, many fundamental questions remain. Our studies will reveal how sumoylation alters TDG
activity and how the SIM mediates these effects. We will also define mechanisms of SUMO conjugation and
deconjugation and learn how the SIM modulates these processes. An in vitro conjugation-deconjugation
system will be used to test the paradigm that sumoylation of TDG is required to regulate its product release
and ensure faithful completion of TDG-initiated BER. Results of these studies will inform how BER deficiencies
impact human health and could suggest new therapeutic approaches for treating diseases including cancer.

Public health relevance
This proposal seeks to elaborate how DNA repair enzymes protect against mutations caused by damage (deamination) occurring to 5-methylcytosine (mC), a modified DNA base that has essential functions in regulating gene expression. A large fraction of point mutations in cancer and genetic disease are attributable to mC deamination. The studies will reveal how repair enzymes counter this threat and inform why these mutations are still prevalent in human DNA. The studies will also reveal how these enzymes contribute to regulating the levels of DNA methylation (mC), which is important because aberrant DNA methylation is implicated in diseases including cancer, and in ageing.